Live microbial therapeutics for enzyme replacement therapy against homocystinuria

Project Summary of Parent Award
The goal of this proposal is to continue the development of a synthetic live bacterial therapeutic for
homocystinuria, an inborn metabolic disorder leading to accumulation of the amino acid methionine, and results
in dramatically increased risk of stroke and other thrombotic conditions. Petri Bio’s approach will be capable of
breaking down methionine in the gut to reduce or eliminate dependence on a methionine restricted diet and
result in decreased plasma and tissue homocysteine resulting in superior clinical outcomes. The condition is
estimated to occur at an incidence of 1 in 250,000, however some reports indicate a potential incidence of 1 in
65,000 when accounting for the current imprecise diagnostic assays and often subtle symptoms which may
evade clinical detection until they become severe or obvious, such as lens detachment from the center of the
eye.Cystathionine beta-synthase (CBS), the gene mutated in classical homocystinuria, is localized at a key
regulatory branch point in the eukaryotic methionine cycle. CBS catalyzes a pyridoxal 5′-phosphate dependent
beta-replacement reaction condensing serine and homocysteine (Hcy) into cystathionine that is subsequently
converted to cysteine in a reaction catalyzed by cystathionine gamma-lyase (CGL, EC 4.4.1.1). Inactivation of
CBS by mutation results in classical homocystinuria (HCU) which in human subjects, is characterized by a range
of connective tissue disturbances including marfanoid habitus and lens dislocation, intellectual impairment, and
a dramatically increased incidence of vascular disorders particularly thromboembolic complications such as
stroke. Treatment strategies for pyridoxine non-responsive HCU typically attempt to lower plasma and tissue
levels of Hcy by a combination of restricting dietary intake of the Hcy precursor methionine and dietary
supplementation with trimethylglycine, more commonly referred to as betaine. Petri Bio, Inc. has developed a
novel strategy for enzyme therapy, employing prokaryotic strains compatible with the human gut microbiome to
serve as expression vectors for therapeutic protein administration. After in silico screening of bacterially-derived
methionases for a number of desirable characteristics of therapeutic enzymes, ten have been cloned, expressed,
and shown to reduce methionine concentrations in vitro. During this Phase I program, we will extend these
studies by screening hundreds of bacterially-derived methionases in silico and subsequently cloning, expressing,
and testing in vitro methionine catalysis capabilities. In vitro tests will be undertaken to measure methionase
activity of these bacterial strains. After optimization of strains with high methionase activity, we will evaluate their
ability to reduce methionine concentrations in vivo, as well as ameliorate the effects of methionine accumulation
in a murine model of HCU. Future studies will optimize the bacterial methionase transgenes to ensure maximum
activity and biocompatibility as well as select a lead candidate bacterial strain for preclinical drug development.

Public health relevance
I. Executive Summary of Predicate SBIR Phase I Grant and Team Classical homocystinuria (HCU) is an inborn metabolic disorder caused by deficiency of cystathionine β- synthase (CBS). This enzyme sits at the branch point between the methionine cycle and transsulfuration and catalyzes the conversion of serine and homocysteine (Hcy) into cystathionine which is subsequently converted to cysteine by cystathionine-ɣ-lyase (CGL) (EC 4.4.1.1) (1). HCU in human subjects is characterized by a range of connective tissue disturbances including marfanoid habitus and lens dislocation, intellectual impairment, and a dramatically increased incidence of vascular disorders particularly thromboembolic complications such as stroke. Petri Bio, Inc. has developed a novel strategy for enzyme therapy, employing prokaryotic strains compatible with the human gut microbiome to serve as expression vectors for therapeutic protein administration. After in silico screening of bacterially-derived methionases for a number of desirable characteristics of therapeutic enzymes, ten have been cloned, expressed, and shown to reduce methionine concentrations in vitro. The goal of our predicate SBIR Phase I grant (Award Number R43HD107885) is to continue the development of a synthetic live bacterial therapeutic for HCU. The specific aims of the proposed research include: Aim 1: Clone and evaluate enzymatic activity of bacterial methionases after in silico screening; Aim 2: Generate human microbiome compatible bacterial strains expressing promising methionases; Aim 3: Test bacterial methionase vector strains in a murine model of HCU. Our proposed I-Corps team will include the following three members: Member Name Role Joseph Schinaman, Ph.D. PD/PI Shu Li, Ph.D. C-Level Corporate Officer (CEO) John Waldeisen, Ph.D. Industry Expert All three members are committed to the time requirements of the program.